Breast-cancer focused biomarker characterization center employing targeted mass spec assays in a CLIA environment

Project Summary/Abstract (Overall Component, RFA-CA-22-040)
We propose to develop a blood-based test whose indicated use is to complement mammography in the early
detection of breast cancers. Although mammography saves lives through early detection, it is imperfect.
Approximately one in seven breast cancers goes undetected despite screening mammography, and interval
cancers that manifest within a year of a normal mammogram remain a vexing problem, especially (although not
exclusively) for the >27 million women in the United States with heterogeneously or extremely dense breasts at
high risk for interval cancers. We propose to develop a blood test that could be used as an adjunct to
mammography to improve early detection by improving sensitivity and/or specificity of mammography. Using a
novel biomarker discovery approach leveraging human-in-mouse breast cancer patient-derived xenograft
models and state-of-the-art mass spectrometry methods, we prioritized 162 candidate breast cancer protein
biomarkers for validation studies.
Our BCC will perform EDRN Phase 2 biomarker validation studies of our prioritized 162 candidate plasma
protein biomarkers of breast cancer. We have an experienced multidisciplinary team (including two junior
investigators) with a strong track record of productive collaboration and representing expertise in clinical
oncology, cancer biomarkers, pathology, CLIA/CAP/GLP assays, epidemiology, radiology/breast imaging,
cancer screening, ‘omics data generation, and biostatistics. Our team includes 2 industry partners, encompasses
3 CLIA laboratories, and can provide expertise and access to multiple quantitative platforms in a CLIA/CAP/GLP
environment to support EDRN Network Collaborations for biomarker validation studies with other BCCs.
The Biomarker Development Laboratory will contribute to the biomarker validation studies by: (i) developing
qualified reagents & methods for quantifying 162 candidate protein biomarkers, (ii) procuring plasma
biospecimens (compliant with EDRN PRoBE study design) for phase 2 biomarker validation studies, (iii)
delivering plasma aliquots to our BRL CLIA labs in a blinded fashion, and (iv) analyzing EDRN phase 2 validation
data generated by the BRL, providing statistical, epidemiological, and breast imaging expertise to set and
evaluate performance metrics to ensure biomarkers are adequate to provide clinical utility for early detection.
The Biomarker Reference Laboratory will contribute to the proposed validation studies by: (i) validating a CLIA-
compliant standard operating procedure for an immuno-MRM assay to quantify up to 162 candidate protein
biomarkers of early-stage breast cancer that will serve as the basis for our biomarker validation studies, (ii)
performing phase 2 biomarker validation studies, and (iii) providing reference laboratory support for the EDRN
network (e.g., mass spectrometric analyses, flow cytometry, NextGen sequencing and ELISA assays.
The Administrative Core will support all aspects of the BCC, including managing all administrative and project
management aspects of the BCC as well as managing all center logistics and communication.

Public health relevance
Project Narrative (Overall Component, RFA-CA-22-040) We propose to develop a blood-based test whose indicated use is to complement mammography in the early detection of breast cancers. Using a novel biomarker discovery approach leveraging human-in-mouse breast cancer patient-derived xenograft models and state-of-the-art mass spectrometry methods, we previously prioritized 162 candidate blood-based breast cancer protein biomarkers for validation studies. This project will perform EDRN Phase 2 biomarker validation studies of our prioritized 162 candidate plasma protein biomarkers of breast cancer, using clinical grade immuno-MRM assays run in our CLIA Laboratories to analyze strongly unbiased collections of plasma to evaluate the performance metrics of single or multiple protein panels in EDRN phase 2 case-control validation studies.